ARCHS4: Massive Mining of Publicly Available RNA Sequencing Data

Summary
This supplement project will contribute to the enhancement of the TragetRanger and GeneRanger web-based
resources. The work will include: 1) Adding HuBMAP as an additional background atlas for GeneRanger and
TargetRanger; 2) Providing the HuBMAP team with feedback about our experience with processing and utilizing
the HuBMAP data for incorporation it in GeneRanger and TargetRanger; and 3) Upgrading GeneRanger and
TargetRanger box plot visualizations to organize the information in ontological hierarchies that group together
cells into tissues, and tissues into organs. The project will be a supplement to the NCI ITCR U24CA264250 grant
that was funded to support the advanced development of the widely accessed resource ARCHS4. Data
processed from ARCHS4 is already incorporated into GeneRanger and TargetRanger but it is currently not
organized into hierarchies. In addition, TargetRanger is mainly useful for discovering novel targets for identifying
and removing cancerous cells in tumors. Hence, the incorporation of HuBMAP data as normal tissue background
will further strengthen our ability to distill useful targets for the removal of specific cells from tumors while causing
minimal damages to normal healthy cells and tissues throughout the human body. Our goal is to make HuBMAP
and ARCHS4 data more accessible to researchers while enabling comparisons with other atlasing projects. By
processing and incorporating HuBMAP datasets into GeneRanger and TargetRanger resources, we can identify
ways to improve the accessibility of HuBMAP data for others seeking to utilize it for analysis, and for adding
value to bioinformatics tools and databases. We believe that this knowledge integration effort will enhance the
utility of HuBMAP, ARCHS4, as well as GeneRanger and TargetRanger for the research community.

Public health relevance
Narrative The project will combine data from HuBMAP and ARCHS4 for the purpose of identifying personalized targets for the development of novel immunotherapies. The identification of cell-surface targets in tumors from individual patients is a critical initial step in the development of novel antibody-drug conjugates and CAR T-cell therapies.